Improving Nursing Home Compare for Dually Eligible Consumers

DESCRIPTION (provided by applicant): Individuals who are enrolled in both Medicare and Medicaid (often called dually eligible or duals) have attracted increased health policy attention in recent decades due to their disproportionate use of health care services and costs. Duals are a vulnerable population as they are generally sicker than the elderly population as a whole, more likely to be in need of long-term care, more likely to receive care in low-resource neighborhoods, and are subject to misaligned and conflicting policy incentives from Medicare and Medicaid. Nursing homes are a major site of care for duals. The nursing home sector has long been a target of concern about low quality of care, and duals are often disproportionately affected by these quality problems. In 2002 the Centers for Medicare and Medicaid Services launched a public reporting initiative (Nursing Home Compare) aimed at improving quality of care for nursing home residents in part by guiding consumers to higher quality nursing homes. However, studies of consumer response to Nursing Home Compare have revealed a small and inconsistent market share response. These lukewarm effects have been disappointing and somewhat puzzling, but they may be masking substantial heterogeneity of effect-duals may be much less likely to respond to, and benefit from, Nursing Home Compare than non-duals. Our preliminary work reveals that, rather than choosing higher-quality facilities, duals have increased their propensity to be admitted to low- quality facilities under public reporting. In this mixed methods project, we propose to examine the extent to which duals have benefited (or not) from Nursing Home Compare, to assess the importance of constrained access by duals in preventing greater use of Nursing Home Compare to choose higher-quality nursing homes, to assess qualitatively the obstacles to duals' use of Nursing Home Compare such that improvements to the report cards may be explored. In particular, information about the quality of nursing homes may not be helpful if an individual 1) lives too far from a high-quality home; 2) depends on Medicaid and no Medicaid beds are available in the high-quality homes; 3) has difficulty accessing or interpreting the quality information. By assessing the relative importance of barriers to effective use of Nursing Home Compare by duals, we will identify the most promising avenues for further investment, e.g. improved usability of quality reports vs improved availability of high-quality providers. These are crucial distinctions affecting access to high-quality care fora particularly vulnerable population.

Public health relevance
PUBLIC HEALTH RELEVANCE: Our overall goal in this study is to improve the quality of care for nursing home residents who are dually enrolled in Medicare and Medicaid ("duals") by critically examining and developing improvements to a major policy initiative -public reporting of quality information- in terms of its effects on, and use by, the duals relative to other consumers. The duals are a particularly vulnerable population responsible for disproportionate health care spending and utilization; thus the effects of major policies on this population is of key policy concern. __SpecificAimsTextDelimiter__ 2. SPECIFIC AIMS Individuals who are enrolled in both Medicare and Medicaid (often called dually eligible or "duals") have attracted increased health policy attention in recent decades due to their disproportionate use of health care services and costs. Duals are a vulnerable population as they are generally sicker than the elderly population as a whole, more likely to be in need of long-term care, more likely to receive care in low-resource neighborhoods, and are subject to misaligned and conflicting policy incentives from Medicare and Medicaid. To improve coordination, the Affordable Care Act of 2010 mandated the creation of the Federal Coordinated Health Care Office devoted to the duals, suggesting this population will receive considerable policy attention for the foreseeable future. Nursing homes are a major site of care for duals; 22% of duals reside in nursing homes and more than half of a typical nursing home population is dually eligible. The nursing home sector has long been a target of concern about low quality of care, and duals are often disproportionately affected by these quality problems. In response to quality concerns, the Centers for Medicare and Medicaid Services launched a public reporting initiative, Nursing Home Compare in 2002 aimed at improving quality of care for nursing home residents in part by guiding consumers to higher quality nursing homes. However, studies of consumer response to Nursing Home Compare have revealed a small and inconsistent market share response. These lukewarm effects have been disappointing and somewhat puzzling, but they may be masking substantial heterogeneity of effect-duals may be much less likely to respond to, and benefit from, Nursing Home Compare than non-duals. Our preliminary work reveals that, rather than choosing higher-quality facilities, duals are more likely than before to be admitted to low-quality facilities under public reporting. In this project, we propose to examine whether and to what extent duals have benefited less from public reporting than non-duals and to establish the primary reasons for a differential effect. A key insight to be tested is that information about the quality of nursing homes may not be helpful if an individual 1) lives too far from a high- quality home; 2) depends on Medicaid and no Medicaid beds are available in the high-quality homes; 3) has difficulty accessing or interpreting the quality information. Our specific aims are: Specific Aim 1 To assess the extent to which duals have benefited (or not) from Nursing Home Compare Hypothesis 1.1 Duals experience smaller improvements in quality than non-duals under Nursing Home Compare. Hypothesis 1.2 Differential improvement in quality for duals and non-duals in response to Nursing Home Compare is due in part to differences in quality improvement across providers and in part to differences in nursing home choice by consumers. Specific Aim 2 To assess the importance of potential barriers in duals' choice of high-quality nursing homes in response to Nursing Home Compare. Hypothesis 2.1 Distance from high-quality nursing homes is associated with lower propensity of duals to be admitted to a high-quality nursing home under Nursing Home Compare. Hypothesis 2.2 Limited availability of Medicaid beds in high-quality nursing homes is associated with lower propensity of duals to be admitted to a high-quality nursing home under Nursing Home Compare. Specific Aim 3 To assess qualitatively the obstacles to duals' use of Nursing Home Compare and to explore improvements to the report cards to address these obstacles. To address the first two Aims, we propose to use a panel of merged Minimum Data Set data; Online Survey, Certification, and Reporting data; and Medicare summary and claims files. The third Aim will entail primary data collection through semi-structured, in-depth interviews with individuals who made decisions about nursing home admission (including the duals themselves as well as their family members and/or other caretakers). Our results will have direct policy implications. By identifying the relative importance of barriers to effective use of Nursing Home Compare by duals, we will identify the most promising avenues for further investment. For example, if level of education and difficulty with accessing and using the information emerges as the most important predictor, policy efforts and resources could be directed toward increased accessibility, and our interviews will provide consumer-driven suggestions for potential improvements. If, on the other hand, distance and Medicaid bed availability dominate as obstacles to benefiting from Nursing Home Compare, then resources devoted to increased accessibility may be wasted and exploration of payment reforms to increase supply of Medicaid beds in high-quality facilities may be more fruitful. These are crucial distinctions affecting access to high-quality care for a particularly vulnerable population.